Determining how cancer cachexia influences gluconeogenesis

Project Summary/Abstract
Pancreatic ductal adenocarcinoma (PDAC) is a devastating and lethal disease associated with peripheral
tissue wasting that is seen in most patients. This progressive wasting condition affecting skeletal muscle as
well as fat and other tissues is referred to as cancer cachexia. PDAC patients with cancer cachexia have lower
median survival than patients without cancer cachexia. There are currently no approved treatments for this
disorder, including nutritional interventions. The Vander Heiden lab in a previous publication identified that the
autochthonous mouse model of PDAC driven by KRAS activation with p53 deletion in the acinar cells of the
pancreas was sufficient to drive cancer cachexia-induced muscle atrophy. These mice exhibited pancreatic
enzyme insufficiency that was identified by the abundance of amino acids and fatty acids within the stools of
cachexic KPC mice, indicating a lack of nutrient absorption. One of the key questions unanswered in the
cancer cachexia field is whether the process of cancer cachexia serves to supply nutrients to the tumor to help
it grow or it functions to help preserve the host. It is unknown where amino acids released from protein
degradation in the muscle are going and what their purpose is. One of the organs in the body that requires an
abundance of amino acids is the liver, as amino acids can be used to fuel gluconeogenesis. The rate-limiting
enzyme for gluconeogenesis is phosphoenolpyruvate carboxykinase (PEPCK), which is upregulated in cancer
cachexia by the IL6/JAK/STAT pathway in the liver. Therefore, we hypothesize that IL6/JAK/STAT signaling
induces PEPCK and gluconeogenesis in the liver to promote cancer cachexia in primary and
metastatic PDAC tumors. I will test this hypothesis in aim 1 by determining the contribution of PEPCK
and gluconeogenesis in the liver to cancer cachexia and vice versa. Then in aim 2, I will study the role
of IL6/JAK/STAT signaling on gluconeogenesis and metabolism in the livers of cachexic mice. Then in
aim 3, I will determine whether cancer metastasis accelerates cachexia through promoting
gluconeogenesis. The outcomes of this study will improve our understanding of whole-body metabolism and
has therapeutic potential to facilitate the development of drug targets for cancer cachexia and/or PDAC.

Public health relevance
Project Narrative Pancreatic ductal adenocarcinoma (PDAC) is a high aggressive cancer associated with a peripheral wasting condition called cancer cachexia that impacts quality of life. There are long-standing questions in the field of cachexia such as where and how amino acids are metabolized during cachexia, and how does this change in metastasis. This proposed research will test whether amino acids contribute to liver gluconeogenesis in both primary and metastatic PDAC, which will provide scientific evidence that can facilitate therapeutic development and improved standard of care for patients.